Behavioral, circuit, and molecular mechanisms underlying UCS deflation

SUMMARY/ABSTRACT
While extinction learning can reduce excessive fear characteristic of anxiety-based disorders like post-traumatic
stress disorder and generalized anxiety disorder, behavioral inhibition achieved through extinction is highly
susceptible to relapse. This is because extinction functions to create a new inhibitory memory while leaving the
original fear memory largely unaltered and intact. We have recently identified and characterized behaviorally a
novel approach to behavioral reduction that seems to circumvent the behavioral relapse common to extinction.
In this procedure, weak versions of the fear-provoking unconditional stimulus are presented to alter the
representation of that fearful stimulus to ultimately weaken fear responding to cues previously associated with
it. The present proposal aims to expand on our understanding of this phenomenon and apply it to novel situations
to reduce behavioral relapse following fear-reducing procedures. Our overarching hypothesis is that
unconditional stimulus deflation will be distinct from extinction at the behavioral, circuit, cellular, and molecular
levels and will be tested in three complementary but independent aims. In Aim 1, we will first directly compare
UCS deflation to extinction in the three most commonly-studied relapse paradigms: renewal, spontaneous
recovery, and reinstatement with the prediction that UCS deflation, but not extinction, will reduce all three types
of relapse. Then, we will test the requirement for neural activity in the IL BLA pathway during UCS deflation in
creating these long-lasting reductions in fear responding using an optogenetic approach. In Aim 2, we will
examine the degree to which extinction and deflation activate the original memory ensemble using a robust
activity marker (RAM) approach. Here, our prediction is that UCS deflation will preferentially activate the memory
ensemble tagged during acquisition, with less activation of this ensemble in extinction learning. We will then
quantify the degree to which the original training ensemble is activated following renewal testing. Here, we
hypothesize more overlap between the neural ensemble in renewal following extinction than following UCS
deflation. Finally, we will test the prediction that the ubiquitin proteasome system will have a unique role in UCS
deflation but not extinction. First, we will examine changes in nuclear and synaptic K48 polyubiquitin tagging
following UCS deflation or extinction with the prediction that UCS deflation will produce changes in the synapse
indicative of memory retrieval and updating whereas extinction will produce changes in the nucleus indicative of
new memory formation. We will then test the hypothesis that blocking proteolytic activity will impair UCS deflation
but not extinction using an intracranial approach. These studies will be the first to examine how UCS deflation
functions to reduce fear across multiple levels of analysis (behavioral, circuit, cellular, and molecular). Further,
they will provide detailed mechanistic insight and identify specific targets through which UCS deflation can
weaken the original learning to persistently reduce fear and render this reduction less susceptible to relapse.

Public health relevance
Project Narrative In the proposed experiments, we will use a novel UCS deflation approach to weaken fear behavior; here, presentations of a weaker version of an unconditional stimulus can produce persistent reductions in fear responding. We will combine behavioral, circuit, cellular, and molecular approaches to gain a detailed understanding of the mechanisms through which weak shock exposure functions to reduce fear behavior and circumvent behavioral responding common to extinction learning. The results from these studies will be immediately applicable to human behavioral treatments aiming to address fear and anxiety behavior long-term.